Midbrain Signals for Differential Reinforcement Learning

Project Summary/Abstract
Associative learning is a fundamental cornerstone of behavior and cognition, but the underlying neural
mechanisms remain poorly understood. In vertebrates, the inferior colliculus (IC) is a layered, midbrain hub
important for sound localization, speech perception, and a potential site of plasticity for associative auditory
learning. Indeed, classic studies in avians showed that neurons of the external “shell” IC layers have a
substantial capacity for plasticity of auditory space maps. Additionally, early mammalian studies suggested that
lesions of the analogous shell IC regions can selectively impair learned auditory associations. Interestingly, the
first- and second-order targets of mammalian shell IC neurons include higher-order auditory thalamic nuclei
and the amygdala, respectively; forebrain regions famously necessary for the acquisition and expression of
associative learning. However, whether learning-related activity in upstream shell IC neurons contributes to
these functions is less clear, owing to the difficulty of studying behaviorally relevant activity in shell IC neurons
via standard techniques. We are addressing this knowledge gap using 2-photon Ca2+ imaging of shell IC
neurons in behaving mice. We find that shell IC neuron activity predicts mice's behavioral choice on a trial-by-
trial basis, implying substantial learning-related activity regarding the behavioral relevance of sounds.
Additionally, many shell IC neurons are strongly active during trial outcomes as mice consume appetitive
reinforcers. These results are exciting, as similar outcome activity is central to reinforcement learning models
and provides an “instructive signal” for learning-related plasticity in many other brain regions. Given this
background, we hypothesize that shell IC neurons are early plasticity loci to associate acoustic stimuli with
reinforcing outcomes, thereby promoting learned instrumental responses to behaviorally relevant sounds. To
test our hypothesis, we established novel cell-type specific methods to record and manipulate activity in shell
IC neurons and/or their downstream targets. We propose applying these approaches as head-fixed mice learn
and execute an appetitive, differential reinforcement task. The results will establish how an evolutionarily
ancient midbrain circuit supports learned associations.

Public health relevance
Project Narrative How the brain associates sounds and their consequences is unknown, but the answer can shed light upon the mechanisms of perceptual learning, habit formation, and language acquisition. This study tests a new hypothesis: Neural plasticity in an early auditory brain region - the inferior colliculus - causally contributes to reinforcement learning. The results will offer new insight into how the brain learns behavioral relevance, which has important implications for atypical processing in disorders such as autism spectrum and schizophrenia.